Integrating Spatial and Single-Cell Transcriptomics with Histology to Define Endotypes in Pediatric Scleroderma

ABSTRACT / PROJECT SUMMARY
Broad Objectives and Health Relevance
Juvenile scleroderma, encompassing systemic sclerosis (jSSc) and localized scleroderma (jLS), leads to
progressive fibrosis and, in the case of jSSc, life-threatening multiorgan involvement. Current treatments rely
on non-specific immunosuppressants that can result in significant toxicities, underscoring the urgent need for
precision therapies. This project aims to characterize molecular endotypes in pediatric scleroderma by
integrating cellular and spatial transcriptomic data with histopathological patterns. These insights will enhance
patient stratification and inform personalized treatment strategies, thereby reducing treatment toxicities and
improving clinical outcomes. The long-term goal is to establish molecularly-guided therapies that transform
care for pediatric scleroderma and contribute to broader fibrotic disease research.
Research Design and Methods
This study will employ single-cell RNA sequencing (scRNA-seq) and spatial transcriptomics (ST) on skin
biopsies from pediatric patients with jSSc and jLS, along with healthy controls. Aim 1 focuses on identifying
cell-specific transcriptional signatures and their spatial relationships, while Aim 2 comprises histopathological
evaluations, which will include both manual annotations of inflammatory and fibrotic patterns and an AI-
assisted approach with further model training. Aim 3 integrates these molecular profiles with histopathological
evaluations and correlates the identified endotypes with clinical phenotypes, disease severity, and treatment
responses, enabling precise therapeutic targeting. By leveraging our collaborative team and patient advocacy
partnerships, this research will directly impact patient care while advancing the field of fibrosis.
Impact
The proposed work will advance precision medicine for pediatric scleroderma by identifying molecular pathways
that drive disease heterogeneity, guiding treatment decisions. This effort aligns with ongoing fibrosis research
and has the potential to inform treatment strategies for other autoimmune and fibrotic conditions.

Public health relevance
PROJECT NARRATIVE This research addresses the significant public health challenge posed by juvenile scleroderma, a rare but devastating autoimmune disease that leads to significant morbidity in children due to progressive skin fibrosis and potential life-threatening organ involvement. By uncovering molecular endotypes through innovative techniques such as single-cell RNA sequencing and spatial transcriptomics, this project aims to develop precision therapies that reduce treatment toxicities and improve patient outcomes. In the long term, our findings will not only enhance fundamental knowledge of pediatric scleroderma pathogenesis but may also inform treatment strategies for other fibrotic and autoimmune diseases, ultimately contributing to better health, extended life, and reduced disability across populations.